Collaborative Research: DMS/NIGMS 1: Identifiability investigation of Multi-scale Models of Infectious Diseases

The emergence and re-emergence of pathogens and their impact on society has reinforced the need for
integration and synergy across scientific fields and biological scales in order to advance understanding,
predicting, and responding to pathogen spread. Multi-scale mathematical models that consider the timing
and length of individual infections when modeling transmission into the population can aid
recommendations for optimal interventions. One shortcoming when evaluating data using multi-scale
models comes from data scarcity in the expansion stages of the infection and transmission, the differences
in data magnitude and frequency at each scale, together with the complexity of the models considered. To
determine the source of combined biases in parameter estimation, we will use a combined empirical-theoretical approach for investigating structural and practical parameter identifiability of multi-scale models
of infectious diseases that may inform optimal experimental design. The proposed research will facilitate a
better understanding of the sources of uncertainty when fitting multi-scale models to multi-scale infectious
disease data, with a focus on Usutu and SARS-CoV-2 viruses. By combining empirical and theoretical
approaches we aim to determine structural and practical parameter identifiability of multi-scale models, to
inform optimal experimental design, and to improve our ability to make predictions and suggest
interventions. Our proposal will focus on three major mathematical challenges: (1) Developing methods for
improving practical identifiability in within-host systems; (2) Use experimental data to inform development of
transmission models; (3) Build a quantitative framework to predict parameter identifiability in multi-scale
systems. The overarching goal of the proposed work is to integrate multi-scale mathematical model
development and statistical models for data fitting with collection of longitudinal virus titers and probability
of transmission data in order to decrease uncertainty and improve results reproducibility. This will ultimately
improve our understanding of infection disease transmission and persistence.

Public health relevance
Synergy across scientific fields is necessary in order to advance understanding, predicting, and responding to pathogen emergence and spread. Our cross-disciplinary approach will leverage mathematical techniques and empirical data by investigating infectious disease transmission at multiple biological scales, with the aim of improving predictions and aiding recommendations for optimal interventions.